Minnesota HHEAR Targeted Analysis Laboratory

PROJECT SUMMARY/ABSTRACT: OVERALL
The Minnesota HHEAR Targeted Analysis Laboratory brings together investigators from the University of
Minnesota and the Minnesota Department of Health with broad and internationally recognized expertise in the
identification and analysis of agents that are potentially harmful to human health at all ages. The combination
of expertises in our proposed laboratory is unique. Our scientists have years of experience in the development
and application of state-of-the-art high throughput analytical chemistry methods based mainly on mass
spectrometry for the assessment of trace amounts of targeted toxicant or carcinogen metabolites in large
clinical and epidemiological studies. Our scientists also have developed and applied methods for the analysis
of DNA adducts of cancer-causing agents in human samples. There are few groups that can bring together a
team with such superb and creative expertise on multiple relevant levels of exposure assessment. Therefore,
our overall goal is to provide human health researchers with access to state-of-the-art infrastructure for
targeted analysis of biological samples. We see this goal as firmly embedded within the concept of the
exposome and its relationship to human health. The specific aims of each component resource and the
development core are as follows.
The Targeted Analysis Resource will use predominantly high throughput mass spectrometric methods with
well-established quality control procedures to provide timely and reliable quantitative data relevant to 3 major
areas of importance to human health: Exposure to tobacco-specific compounds; exposure to environmental,
lifestyle, and nutritional toxicants and carcinogens; and variations in levels of endogenous electrophiles and
dietary compounds.
The Developmental Core will establish new high throughput methods to measure multiple classes of toxicants
and biomarkers in urine, plasma, hair, and toenails; to detect nutritional biomarkers from the intake of foods
and beverages in urine and plasma; to develop assays to detect a panel of internal biomarkers of stress in
multiple biospecimens; and expand our approaches to detect DNA adducts in saliva, blood and formalin-fixed
tissues.
The Administrative Core will coordinate all activities within the Minnesota HHEAR Targeted Analysis
Laboratory. In addition, this core will be the primary link to the HHEAR Coordinating and Data Centers as well
as the HHEAR investigators at all stages of their projects.
Collectively, the Minnesota HHEAR Targeted Analysis Laboratory will contribute to a productive and effective
HHEAR network designed to understand the impact of environmental exposures on human health.

Public health relevance
PROJECT NARRATIVE: OVERALL The Minnesota HHEAR Targeted Analysis Laboratory brings together highly talented scientists from the University of Minnesota and the Minnesota Department of Health to provide a national resource for exploring environmental, lifestyle, and related factors that can affect human health. Scientists from around the United States studying health issues will use this resource to provide critical information about the role of environmental exposures in human disease. The outcome will lead to more effective disease prevention strategies.